Elucidating function of the novel PINX1-related protein, Chigno, in reproductive stem cells and development

PROJECT SUMMARY:
The germline stem cell (GSC) niche functions to ensure continuous gamete production in organisms that
reproduce sexually. Dysregulation of stem cells has also been linked to developmental disorders, cancer,
infertility, and senescence. In flies and mammals alike, communication between GSCs and the surrounding
soma regulates the balance between stem cell maintenance and differentiation. However, new and
unexplored mechanisms regulating these processes are still being discovered - necessitating further enquiry.
This proposal strives to elucidate the function of a novel PINX1-related protein, CG11180/Childless Gambino
(Chigno), in regulating reproductive stem cell behavior and development in the fruit fly, Drosophila
melanogaster.
Chigno is a novel G-patch domain-containing protein in flies that is related to the mammalian tumor
suppressor, PINX1. We previously identified Chigno as a binding partner of Chronologically inappropriate
morphogenesis (Chinmo), a key regulator of somatic stem cell behavior in the adult Drosophila testis.
Preliminary data collected by undergraduate and master’s student researchers in our lab show that Chigno is
expressed in larval and adult testes, as well as Drosophila ovaries and early embryos. In adult testes, Chigno
is observed specifically at the testis apex, which houses the germline stem cell (GSC) niche. Here, it is
detected both in germ cells as well as somatic cyst stem cells (CySCs) and their progeny which regulate
germline behavior. We also find that Chigno knockdown in adult CySCs and early cyst cells results in CySC
over-production, formation of germ cell tumors, and an expansion of epithelial cells at the testis apex that may
be linked to altered CySC identity. Furthermore, somatic Chigno depletion causes both testis and ovaries to
become infertile.
Experiments in this proposal are focused on understanding the role of Chigno in regulating testis stem
cell self-renewal, differentiation, and cell fate maintenance (Aim 1), understanding Chigno protein function at
the molecular level (Aim 2), and assessing whether Chigno functions in tissues other than the testis, including
Drosophila ovaries and embryonic tissues (Aim 3). Given Chigno’s impact on fertility and testes stem cell
behavior, as well as the diverse functions of G-patch/PINX1-related proteins in a range of cellular processes,
the proposed studies into Chigno function hold great promise for elucidating novel mechanisms controlling
fertility, stem cell behavior, and development in a range of organisms.

Public health relevance
PROJECT NARRATIVE: Stem cells are critical for organ function and tissue maintenance. Here, we propose to examine function of the novel gene, Childless Gambino (Chigno), which is required in reproductive stem cells to ensure fertility and prevent tumor formation in the fruit fly, Drosophila melanogaster. As Chigno is most closely related to the mammalian protein, PINX1, which is also produced in reproductive tissues, this work promises to identify new mechanisms for regulating stem cell behavior that have implications for understanding human infertility and cancer.